Investigating Fear System Myelination in PTSD Using In Vivo and Post Mortem Data

PROJECT SUMMARY/ABSTRACT
This proposal will examine maladaptive gray matter (GM) myelination as a candidate mechanism underpinning
two functional brain abnormalities well established in Posttraumatic Stress Disorder (PTSD): hyper-
connectedness of the threat response network (TRN: defined as hippocampus (HIP), amygdala (AMYG),
anterior insula (INS), and dorsal anterior cingulate cortex (dACC)), and disruption of the default mode network
(DMN). Experience- and activity-dependent GM myelination have been observed in many brain regions and
have broad relevance to psychiatric disorders. While experience-dependent myelination evolved to accelerate
nerve conduction, myelination in GM has been shown to reduce synaptic density and synapse-based
neuroplasticity in animal models. Our model proposes that excess GM myelination in the TRN in PTSD results
in a hyperconnected salience network (SN; which includes AMYG, dACC, and INS but not HIP. See “Bridging
Frameworks” section) and a poorly connected and hypoactive DMN. Given that myelin development and re-
myelination in both cortical and subcortical GM are responsive to therapeutic agents, confirming our model
could lead to novel targets for treatment of PTSD, a condition that has resisted pharmacotherapeutic
intervention. Our proposed model yields a candidate mechanism underpinning the “synaptic disconnection”
syndrome proposed by Krystal and colleagues to explain impaired functional brain connectivity in PTSD. It is
also noteworthy that recent evidence suggests that DMN dysconnectivity in PTSD is not associated with the
disruption of large frontal white matter tracks. As such, excess GM myelination in key structures may supply an
explanation for this phenomenon. Using a combination of postmortem neuropathology in PTSD cases versus
brain bank controls, and in vivo neuroimaging at 3T in a matched case control design, we will examine if PTSD
is associated with increased myelin content and decreased synaptic and neurite density in the TRN structures.
Finally, we will test if increased GM myelin and decreased neurite density in TRN account for increased resting
state (RS) connectivity within the SN and decreased RS connectivity within the DMN in the same living
subjects. Integration of postmortem neuropathology, afforded by the National PTSD Brain Bank, and in vivo
neuroimaging will enable a highly novel but broadly testable exploration of GM myelination and its
consequences in the human brain as modified by PTSD.

Public health relevance
PROJECT NARRATIVE The project will test the hypothesis that PTSD is associated with changes in gray matter myelin content which affect functional circuits. The project involves the study of postmortem brain tissue from the National Center for PTSD Brain Bank as well as living subjects studied with brain imaging.